Developing a novel antibiogram tool to improve empiric antibiotic prescribing in nursing homes

PROJECT SUMMARY/ABSTRACT
Inappropriate antibiotic use is a common problem that contributes to adverse drug events and antibiotic
resistance in nursing homes (NHs). Empiric antibiotic selection decisions in NHs are frequently suboptimal.
Cumulative susceptibility reports based on patient cultures, known as antibiograms, are tools increasingly being
used to improve empiric antibiotic decisions in NHs. However, most NHs collect an insufficient number of cultures
to permit creation of reliable facility-specific antibiograms causing many facilities to turn to pooled facility
antibiograms. Antibiograms based on combining culture data from multiple facilities improve the reliability of
reported susceptibility estimates and accurately reflect regional antibiotic resistance patterns but may present a
distorted picture of susceptibility patterns at the local level. Consequently, it is possible that increasing use of
pooled facility antibiograms may worsen rather than improve empiric antibiotic decisions in NHs.
The weighted-incidence syndromic combination antibiogram (WISCA) is a novel method that makes better use
of available microbiology data when culture results are scarce. A WISCA also presents data in a manner that
may reduce cognitive load on clinicians. We believe WISCAs will prove to be more reliable than traditional
antibiograms and exert a greater effect on empiric antibiotic decisions in NHs. The objectives of this study are to
develop a user-friendly WISCA tool, compare it to a traditional antibiogram and develop a toolkit for its
implementation and evaluation in NHs. We will achieve these objectives through the following specific aims:
In Aim 1, we will conduct a prospective surveillance study in 82 NHs in four states to characterize antibiotic
susceptibility patterns in NHs using traditional antibiograms and WISCAs. Existing study NH culture data will be
obtained from their reference laboratories. The reliability of the two antibiogram formats will be evaluated and
the congruence between single and pooled facility susceptibility estimates will be estimated.
In Aim 2, we will develop a user-friendly WISCA format with input from NH clinicians. The resulting tool will be
evaluated using a simulated case-study approach in which 300 NH clinicians will be asked to complete several
clinical vignettes describing common NH urinary syndromes. Participants will be randomized to complete the
vignettes using either clinical information alone or with the assistance of a pooled antibiogram or a WISCA tool.
Appropriateness of antibiotic decisions will be compared across the three study arms.
In Aim 3, we will perform a facilitated implementation pilot study in 6-10 NHs in order to develop a toolkit for
implementing and evaluating the WISCA intervention. We will use a mixed-methods approach, structured around
the SEIPS model and Theoretical Domains Framework, to identify implementation barriers and enablers in study
NHs and to identify and design strategies to enhance adoption of the WISCA intervention. Outcomes from this
work will be used to develop a large-scale pragmatic clinical trial to assess the effects the WISCA has on
antibiotic decisions in a real clinical practice environment.

Public health relevance
PROJECT NARRATIVE Empiric antibiotic selection decisions in nursing homes (NHs) are frequently suboptimal, threatening resident safety by increasing risks of adverse drug events and antibiotic resistance. Cumulative susceptibility reports based on patient cultures, known as antibiograms, are increasingly used in NHs to help guide empiric antibiotic decisions. Most NHs collect an insufficient number of cultures to permit development of a facility-specific antibiogram. In this study, we propose to develop and evaluate an alternative approach to characterizing local susceptibility patterns in NHs, called a weighted incidence syndromic combined antibiogram (WISCA). This work will also lead to the development of a toolkit to support the implementation and evaluation of WISCAs in NHs. Outcomes from this work will help support future studies examining the effects of WISCAs on antibiotic decisions in NHs. We are optimistic that this and subsequent research in this area will lead to tangible improvements in the quality and safety of antibiotic use in NHs.